Triterpenoids in mitigation of radiation induced acute or delayed inflammation

Project Summary
Currently, there is a need for strategies that mitigate acute and delayed radiation syndrome. The risk of large
populations encountering radiation exposure is real and growing. Radiation induced inflammation plays
significant role in inducing radiation toxicity. Chemokine signaling plays key role in systemic and local
inflammation by modulating egress and recruitment inflammatory immune cells such as inflammatory monocytes
and T cells. Radiation exposure induces recruitment of inflammatory cells and promotes systemic and local
inflammation. We have observed that deletion of genes expressing chemokine receptor 2 in mice promotes
resistance radiation induced acute and delayed inflammation. Triterprenoids are very potent anti-inflammatory
agents. Recent findings suggest that synthetic derivatives of oleanolic acid that are more potent at suppressing
production of the inflammatory mediator such as chemokine ligand 2. Under NIAID Chemical Countermeasures
Research Program (CCRP) Triterprenoids such as CDDO- methyl ester (CDDO-Me) has been shown to mitigate
chemical induced ocular injury by nrf2 dependent manner. In this proposal we will examine the effect of CDDO-
Me against radiation induced acute and delayed inflammation using mice model of radiation
induced gastrointestinal syndrome and radiation induced pulmonary syndrome respectively. We will also
characterize the effect of CDDO-Me in modulation of bone marrow derived inflammatory immune cell
recruitment in injured tissue. Determination of mechanism of action of will facilitate CDDO-Me as a medical
countermeasure against radiation under the FDA’s Animal Rule.

Public health relevance
Project Narrative The proposed research will characterize Triterprenoid therapy to mitigate radiation injury and inflammation with efficacy at 24 hours after radiation exposure. This proposal will also define the mechanism of action of the countermeasure which will provide data necessary for product licensure requirements according to the FDA Animal Rule. Successful completion of this project will lead to the development of this Triterprenoid therapy as a medical countermeasure to treat inflammation and injuries resulting from a radiation or nuclear accident.